Microphysiological Human Tissue Systems for Monitoring of Genome Editing Outcomes

Abstract:
Genome editing technologies have significant potential to treat a variety of devastating human diseases and
disorders. However, there are a number of challenges that genome editing therapies must overcome to reach
their full promise. Specifically, there are many possible adverse consequences that are unique to genome editing
tools, such as genome integrity, immune responses, and loss of therapeutic efficacy due to cell turnover, for
which there are currently are no optimal systems for rigorous assessment. Moreover, these consequences are
unique to human physiology, genome sequence, and immune systems, and therefore typical animal models are
not completely informative. To address this unmet need, we have assembled a team of collaborative
investigators that have developed advanced genome editing strategies and methods for engineering human
microphysiological tissue systems that recapitulate human physiology and function, with an emphasis on skeletal
and cardiac muscle. We will combine these technologies in this proposal to systemically evaluate tissue
physiology, genomic alterations, tissue regeneration, and immune response in response to various genome
editing strategies and delivery methods. Specifically, this will include comprehensive and unbiased mapping of
unintended modifications to human genome sequences, including at on-target and off-target sites. We will also
determine the role of resident tissue stem cells, cell turnover, and tissue injury and regeneration in the stability
of genome editing. Finally, we can incorporate immune cells into these microphysiological tissues to understand
the consequences of immunity to bacteria-derived genome editing components. Collectively, this proposal will
develop a platform to systematically address the most significant challenges to realizing the transformative
potential of genome editing therapies in human tissues.

Public health relevance
Narrative: Genome editing is a transformative technology that has the potential to treat diverse human diseases, but systems do not currently exist to monitor possible adverse consequences of this approach in human tissues. This proposal combines advanced tissue engineering approaches to systematically and quantitatively assess the effects of various genome editing methods on tissue physiology, function, and regeneration, as well as genome integrity and immune system responses. The focus of this project is on skeletal and cardiac muscle, which are tissues that are severely affected by many genetic diseases with significant unmet clinical need.